Administrative Core

PROJECT SUMMARY – ADMINISTRATIVE CORE
The Administrative Core provides the organizational structure and scientific leadership that supports and
promotes our interdisciplinary research program designed to achieve advances in diagnosis, prevention, and
treatment of intellectual and developmental disabilities (IDD). The diverse functions of the core have been
critical in creating a highly visible, innovative, and comprehensive center that systematically advances and
integrates all aspects of research, training, and clinical services to promote basic and translational science in
the field of IDD at the University of Washington. Our specific aims are: 1. To develop new and coordinate
existing scientific resources to support the research of IDDRC Research Affiliates; 2. To promote
interdisciplinary and collaborative research in high priority areas in IDD; 3.To further connect research and
clinical activities, strengthen community partnerships, and conduct a comprehensive dissemination and
outreach program; and 4. To support the development of future investigators in the field of IDD.